HBV Capsid Effectors

PROJECT SUMMARY/ABSTRACT Despite the availability of an effective vaccine, epidemiologic data estimates about 2 billion people globally are infected with hepatitis B virus (HBV). Approximately 350 million people are chronic HBV carriers and at high risk for the development of hepatitis, cirrhosis and hepatocellular carcinoma. Current anti-HBV treatment options suppress the virus but do not cure, requiring costly lifetime therapy. Thus, discovering and developing novel therapeutic approaches to not only suppress viral replication, but also eliminate HBV infection is key. Current approved therapeutic approaches fail to target the HBV covalently closed-circular DNA (cccDNA; associated with viral persistence) or the virus capsid which is essential for virus proliferation. Our innovative approach targets capsid assembly which is essential for replication, as DNA synthesis from cccDNA occurs exclusively within the capsid encoded particle. HBV core proteins (Cp) constitute the subunits in viral capsid assembly and Capsid Assembly Modulators (CAM) accelerate the kinetics of capsid assembly whereby they prevent pol-pgRNA complex encapsidation and block HBV replication. CAMs also interfere with cccDNA transcription/de novo formation during early steps of infection. As part of our ongoing HBV CAM discovery program NIH-supported over the last 5 years, we have been successful in developing several highly potent class II CAMs with one lead compound entering phase 1 clinical trials in October 2020. To advance the field and have back up compounds with improved profile, we recently identified several CAM homo- and hetero-dimer derivatives displaying anti- HBV activity in culture in the picomolar range. Because a dimeric structure linking two CAM moieties can interact with two distinct sites of one capsid or eventually connect two capsids together, we hypothesized that these compounds would have a more profound impact on HBV capsid assembly than known class I or II CAMs. Based on the potency and the unique mode of action of these compounds (which we call Class III), we propose to evaluate them by pursuing three specific aims: 1) To chemically optimize and characterize a unique series of CAM homo and heterodimers; 2) To structurally, biochemically, and biologically characterize novel CAM homo and heterodimers binding interaction with HBV capsid; 3) To determine pharmacokinetics and in vivo efficacy of novel CAM homo and heterodimers. Novel homo and heterodimers will be synthesized and evaluated to reach maximum potency and drug-like properties. To differentiate our compounds from existing class I and II CAMs, we will characterize structural and dynamical effects of our new CAMs by determining a) their effect on the morphology of HBV capsids and their localization within cells, b) binding to HBV wild type and known mutant Cp, c) resistance profile and activity against major CAM resistant HBV strains and d) intra- or inter-capsid connections. Results from the proposed studies will validate our novel class of CAM, which, when combined with other modalities could provide preclinical proof of concept towards a novel therapeutic strategy to eliminate HBV while reducing treatment duration and also eliminate progression to other complications.

Public health relevance
PROJECT NARRATIVE Despite the availability of an effective vaccine, epidemiologic data estimates about 2 billion people in the world are infected with hepatitis B virus (HBV) and approximately 350 million people are chronic HBV carriers and at high risk for the development of hepatitis, cirrhosis and hepatocellular carcinoma (HCC). Current treatment options suppress the virus but do not cure, requiring costly lifetime therapy. The goal of this proposal is to validate our novel class of highly potent Capsid Assembly Modulators (CAM), which, when combined with other modalities (e.g., nucleoside analogs), could provide preclinical “proof of concept” towards a novel therapeutic strategy to eliminate HBV and with potential to reduce treatment duration and eliminate progression to HCC.